Soy Isoflavones for Inner City Infants at Risk for Asthma (SIRA)

Abstract:
A frequent gain of function promoter polymorphism for the PAI-1 gene (~60% of the population are
homozygous or heterozygous) is associated with elevated circulating PAI-1 levels. Children homo or
heterozygous for this allele who had a medically attended respiratory viral illness before age 2, had a 12 (any
virus) to 18-fold (RSV) increased risk of asthma. The mechanisms for this association are not established. PAI-
1 is associated with airway thymic stromal lymphopoietin (TSLP) production, which promotes Th2 type airway
responses. Furthermore, the PAI-1 overproducing genotype is associated with increased serum levels of IgE.
IgE elevation increases FcεRI levels on pDCs which attenuates type I interferon antiviral responses. Of note,
soy isoflavones reduce TGF-1-induced PAI-1 gene expression and protein production from airway epithelial
cells, and have been shown to decrease the risk of asthma exacerbations by 70% in individuals with the
genotype. It is not known whether supplementation with soy isoflavones will decrease the risk of developing
Th2 airway inflammation or the likelihood of allergic sensitization if it is given to children at risk of asthma in the
first year of life. Soy Isoflavones for Inner City Infants at Risk for Asthma (SIRA) is a single center,
prospective randomized, quadruple masked trial of high-risk infants with the PAI-1 genotype to compare
supplementation with soy genistein at doses similar to soy formula ingestion or placebo during peak viral
season of the first year of life. Children aged 2-6 months at enrollment will be randomized to soy isoflavone or
placebo in August, receiving active treatment from August to March 1st, followed by observation over the next
year for each yearly cohort. The objective of this proposal is to determine 1) whether soy isoflavones can
modulate development of Th2 airway endotypes, decrease eosinophilic airway inflammation, and reduce
sensitization in high risk infants with the PAI-1 risk genotype, and 2) decrease IgE production via effects on
PAI-1, and thereby improve rhinovirus-induced IFN-α response. As such, the primary outcome of the trial will
be the development of T2 airway endotypes by interrupting the PAI-1/TSLP axis. Secondary outcomes will
include nasal PAI-1, nasal ECP, nasal Th2 cytokine levels, serum periostin, total and specific IgE, and
respiratory morbidity. The secondary aim will determine if antiviral IFN-α responses by PBMC stimulated by
HRV and IgE crosslinking are augmented by soy genistein in a similar fashion as has been described for
omalizumab. Secondary outcomes for this aim will evaluate if soy genistein will augment IFN-α responses by
pDC in similar experiments. The current project uses a safe and inexpensive intervention, soy genistein,
directed to a common genotype as a precision medicine approach to provide a better understanding of key
pathways relevant to development of allergic airway inflammation in early life. If confirmatory, these results
would lead into intervention trials focused on clinical outcomes. This line of inquiry has the potential to benefit a
large number of children at risk of developing asthma.

Public health relevance
Narrative: Pediatric asthma, against which there are no proven prevention strategies, results in significant cost to families and society ($5.92 billion annually) with increased risks emergency department visits, hospitalization, and missed work/school. Soy Isoflavones for Inner City Infants at Risk for Asthma (SIRA) is a precision medicine study, directed to a functional genetic variation in the PAI-1 gene which is present in 60% of the population, that seeks to determine if soy genistein, a safe and inexpensive nutritional product given in the same doses found in soy formula, can decrease the risk of developing allergic airway inflammation and allergies in young infants with this genetic variant. If the study confirms these effects, it would lead into intervention trials focused on asthma prevention, and has the potential to benefit a large number of children at risk of developing asthma.